STRUCTURAL AND FUNCTIONAL ANALYSIS OF CLONED MHC GENE

We have prepared genomic and cDNA clones including MHC gene products expressed in B cells, T cells, and teratocarcinoma cells. We will extend these genomic clones with the ultimate goal of obtaining the entire chromosomal region embedding the MHC complex in overlapping genomic clones. We have cloned and sequenced the genes for HLA-B7, HLA-A2 and another previously unidentified class I antigen, and the genes for HLA-DR and SB-alpha chain. We will characterize the DNA controlling the expression of gene products in different types of cells or cells at different stages of differentiation. We have constructed a range of recombinant HLA-B7 clones and are studying their expression in injected mouse embryos. (P)